Evaluating the Efficacy of Telehealth-Delivered Brief Family Involved Treatment (B-FIT) for Alcohol Use Disorder among Veterans

Improving alcohol use disorder (AUD) treatment access and outcomes among Veterans
is an urgent public health priority. The lifetime prevalence of AUD among Veterans is
twice that of civilians. Veterans also incur more severe and persistent AUD symptoms
with more lengthy and complex treatment courses and negative outcomes compared to
the general population. Despite the critical role that family members play in the etiology,
course, and treatment of AUD, and the robust evidence base supporting the efficacy of
several existing family AUD treatments, family treatment protocols are lengthy and
burdensome for patients and clinicians. Thus, there is a critical need to develop
efficacious family AUD treatments that are both brief and highly accessible to Veterans.
Members of our team developed and refined the Brief Family Involved Treatment (B-FIT)
protocol in an NIAAA-sponsored pilot trial among civilians. B-FIT is a 3-session cognitive
behavioral therapy designed to be implemented in combination with any existing alcohol
treatment program. The goals of B-FIT are to 1) increase reinforcement of treatmentfacilitating
behaviors, 2) increase the perceived reinforcement value of abstinence by
increasing anticipated positive rewards from abstinence, and 3) reduce drinking cues by
decreasing negative communication and increasing positive communication with family
members. This study resulted in findings that support feasibility, acceptability, and
preliminary efficacy of B-FIT. In a separate study, our team has demonstrated excellent
feasibility and acceptability of delivering dyadic AUD treatment via home-based
telehealth. Thus, the primary objective of this Stage II trial is to examine the efficacy of
B-FIT in combination with treatment as usual (TAU; CBT) versus TAU alone in 1)
reducing alcohol consumption, 2) improving family functioning, and 3) improving
treatment satisfaction, adherence, and retention among Veterans. To accomplish this,
we will employ an open randomized controlled design and examine standardized,
repeated, dependent measures of change at multiple time points. We will also leverage
our team’s standard operating procedures for fully remote study implementation, close
collaboration with regional VA clinics, and a robust national VA telehealth infrastructure
which is prepared to efficiently translate positive findings into treatment. The proposed
study is directly aligned with NIAAA’s mission and Strategic Plan in that it will 1) employ
electronic health technology to improve the effectiveness and accessibility of AUD
treatment for Veterans, 2) will advance AUD treatment access among Veterans with less
access to treatment, 3) focuses on Veterans in a real-world treatment setting (i.e., VA
clinics), 4) examines B-FIT for home-based telehealth delivery, and 4) will identify
characteristics of Veterans and family members most likely to benefit from the addition of
B-FIT to their recovery program. Our findings will directly inform clinical practice and
accelerate treatment in this important but understudied area.

Public health relevance
Veterans are a high risk AUD population and incur persistently limited access to efficacious family AUD treatments. This study will address longstanding gaps in the literature by examining the efficacy of Brief Family Involved Treatment (B-FIT), delivered via telehealth (i.e., videoconferencing), to maximize AUD treatment outcomes among Veterans. This study will address an urgent public health priority, significantly advance the science in this area, and improve treatment access to reduce the prevalent, deleterious, and costly effects of AUD among Veterans.